EQUIPMENT for Designing a new class of fluorescent reporters for imaging dynamic cell signaling in live animals

The abstract of the funded parent award is contained in the 2 page Research Strategy attachment required under NOT-GM-21-030. (See Research Strategy Section).

Public health relevance
See Research Strategy Section, for project narrative.